FLUORESCENT DIFFUSE OPTICAL TOMOGRAPHY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Duke Center for In Vivo Microscopy (CIVM) develops and supports leading edge technologies for small animal medical research including MRI, micro-CT, ultrasound, optical microscopy and optical tomography. This collaborative project is to enable the widespread use of fluorescence diffuse optical tomography (FDOT) by applying supercomputing techniques to improve its resolution and sensitivity.